First in Human Clinical Trial of a Contraceptive MPT YASO GEL

PROJECT SUMMARY
Polyphenylene carboxymethylene sodium salt (PPCM) is being developed by Yaso Therapeutics as a woman-
controlled, on-demand vaginal gel (YASO-GEL) that is both contraceptive and microbicidal. We have advanced
PPCM and YASO-GEL through preclinical evaluation, successfully submitted our IND, and are ready for clinical
evaluation.
In this application, we propose to conduct a Phase 1 First-in-Human clinical trial to evaluate the safety and
pharmacokinetics of genital use of YASO-GEL in women and men. In addition to standard safety testing and
pharmacokinetics, we will conduct assays to assess the impact of YASO-GEL on the vaginal microbiome and
immune factors. We will also gather preliminary data on the efficacy of YASO-GEL in the vagina by evaluating
the sperm in post-coital samples for motility, viability, and acrosome loss. Microbicidal activity against both
Neisseria gonorrhoeae and HIV will also be assessed in ex vivo samples.

Public health relevance
NARRATIVE There is a critical need for more and better contraceptive choices, especially ones available over the counter. Millions of American women cannot obtain a contraceptive method that works for them. Many women have distressing side effects from hormonal contraceptives and distrust methods that contain hormones. Women find their partners may not cooperate with condom use.19 million American women live in contraceptive deserts, where medical services do not offer the full spectrum of available contraceptive methods. Furthermore, the cost may be prohibitive because the contraceptive mandate under the ACA has been badly diluted at the state level, resulting in high cost-sharing penalties which are not affordable for many women. In many cases, corporations have the choice to not insure contraceptives at all. In this grant we will avoid many of these barriers. YASO-GEL. promises to be a safe, non-irritating, pleasant, vaginal gel that could be approved directly as an OTC drug product YASO-GEL may also prevent gonorrhea and possibly other STIs. It would not require medical services, is woman-controlled, and has excellent preclinical safety. It uses relatively low-cost raw materials and simple production methods. In this grant we will have our first human safety and preliminary efficacy data which will guide all future development of this novel MPT contraceptive drug product. Our goal is to produce a low-cost, profitable, pleasant, safe, effective, and accessible vaginal contraceptive that is sold OTC wherever condoms are sold today.